Developmental Funds

PROJECT SUMMARY/ABSTRACT
DEVELOPMENTAL FUNDS
Winship Cancer Institute of Emory University (Winship) utilizes CCSG developmental funds in combination with
philanthropic and institutional funds to drive strategic priorities and foster innovative cancer research. During the
current cycle, funds were utilized to support two developmental shared resources: the Winship Data and
Technology Applications Shared Resource (Data SR) and the Intervention Development, Dissemination, and
Implementation Shared Resource (Dissemination SR). Both have advanced to full shared resources in this
application. Funds were also used to support the Winship Invest$ pilot grant program. Winship Invest$ follows
bi-annual funding cycles and a standardized peer-review process. A custom technology platform is utilized to
manage the pilot grant program. This platform is integrated with the Winship administrative database and
integrates funding, outcomes, and membership data. It is also used to manage documents, member surveys,
and the review process. Winship Administration has established post-award processes to monitor funds and
provide reports for leadership evaluation of program effectiveness. During the current funding period, CCSG
developmental funds ($900,000) were awarded to 15 pilot projects and resulted in receipt of $2.6 million of
external funding to date. CCSG funded awards from prior period (2013-2017, 24 awards, $778,000) resulted in
$14.4 million external funding with average time of 30 months to first funding after award start date. Similar
growth is anticipated for pilot funds from the current funding period. Winship also distributed $5.1 million in
philanthropic, institutional, and other peer-reviewed funds during the reporting period for a total of $6 million
allocated to 122 pilot awards and leading to $16.4 million in external funding. Findings from CCSG-funded
research have been disseminated in high impact journals such as Nature, Nature Cancer, Nature
Communications, and Journal of Clinical Oncology. Winship developmental funds have resulted in other
noteworthy outcomes, such as the advancement of multidisciplinary team science research, career development
for junior investigators, health disparities research, and performance of investigator-initiated clinical research.
This competitive renewal requests developmental funds for continued support of Winship Invest$ with plans to
fund 15-20 pilot grants with award amounts of $50,000 to $100,000 each. To build a pipeline of clinical trials
development expertise, Winship also plans to fund one early-stage clinical investigator award per year with each
award providing two years of support. Developmental funds in combination with institutional and philanthropic
funds are a critical resource for the Executive Director and the leadership team to strategically support innovative
research ideas and develop new research themes. These funds will enable Winship to continue its growth as a
transformative leader integrating cancer research, education, care, and community impact to achieve its mission.